HEMODYNAMIC AND NEUROHORMONAL EFFECTS OF INDUCED SODIUM RETENTION

Comparison of the systemic hemodynamic and neurohormonal changes in patients with alcoholic cirrhosis who either develop ascites or escape the effects of as administered mineralocorticoid.